Phage-Polymer Nanoparticles for Treatment of Antibiotic-Recalcitrant Wound Biofilm Infections

Project Summary
Phage-Polymer Nanoparticles for Treatment of Antibiotic-Recalcitrant Wound Biofilm Infections
Wound biofilm infections are associated with significant morbidity, mortality, and cost, and can be refractory to
conventional antibiotic treatment. The proposed research will create new polymer-phage conjugates to treat
wound infections. Phage therapy provides a self-amplifying strategy to combat bacterial infections. However,
phages do not efficiently penetrate into the dense biofilm matrix, limiting the efficacy of phage therapies for
treating biofilm infections. These issues will be addressed through integration of nanomaterials developed by
Rotello with the in vitro, in vivo, and clinical expertise of Patel in phage therapy.
In published studies, Rotello and Patel demonstrated that engineered polymers can encapsulate phages to
generate non-covalent protein-phage nanoparticles (PPNs) that retain infectivity and feature enhanced efficacy
against biofilms relative to free phage in vitro and in vivo. In the proposed research, Rotello will develop new
homopolymers and block copolymers to generate polymer-phage conjugates, focusing on Phage K that Patel
has shown has cross-strain and cross-species activity. These polymers will use a cationic block to
electrostatically anchor the polymer to phages. One PPN family will systematically vary the hydrophobicity of the
homopolymer to optimize biofilm penetration and eradication. The second PPN polymer will feature an exterior
block with charge-switchable functionality that will go from anionic (non-interacting) to cationic (biofilm
penetrating) at biofilm pH, providing targeted delivery of PPN. Conjugates will be screened in vitro against
methicillin-resistant Staphylococcus aureus (MRSA) planktonic bacteria and biofilms. Effective PPNs will be
incorporated into hydrogels, with hydrogel porosity used to provide controlled PPN delivery. Conjugates effective
in vitro will be screened in a realistic murine wound biofilm by Rotello. Patel will then perform pre-clinical studies
of the antimicrobial and wound healing efficacy of PPNs, supported by histopathology.
Aim 1: Rotello will synthesize homo- and block copolymers and non-covalently conjugate them to phages specific
against MRSA study isolates. Infectivity of the conjugates will be quantified and will be tested for biofilm
penetration and eradication. Patel will establish cross-strain and cross-species activities of phages.
Aim 2. Rotello will incorporate effective PPNs into hydrogels to provide wound dressings with controlled release
of phage. Our expectation is that control of hydrogel pore size will regulate PPN release, providing optimal phage
activity.
Aim 3. Rotello and Patel will use murine wound biofilm models to test PPN-hydrogel wound dressings. These
studies will combine parametric pilot experiments using luminescent MRSA by Rotello with full pre-clinical
evaluation by Patel. Efficacy in these models will be quantified by decreased bacterial counts, enhanced wound
healing, diminished purulence, and decreased inflammation as outcomes.

Public health relevance
Project Narrative The goal of the proposed research is to develop polymer-bacteriophage conjugates for treatment of wound biofilm infections. These challenging infections occur across the population and are rapidly increasing in incidence and severity. The proposed study will provide a new modality for treating these dangerous and expensive of multidrug resistant wound infections.